Using Neuroimaging Markers to Understand Risk Factors and Consequences of Cannabis on Brain Structure and Function

Project Summary
This application for an Independent Scientist Award (K02) requests support to develop a program of
brain-based and behavioral research on substance use disorders (SUD), especially cannabis use disorder
(CUD). My laboratory is supported in part by a funded R01 (DA039135) that seeks to understand the effects of
medical marijuana on the brain, cognition, and escalation to CUD. In the next phase of my career, I propose to
learn enhanced analytical techniques (e.g. machine learning and predictive modeling) that can capitalize on
newly-available, large, longitudinal datasets that can answer fundamental questions about the development of
SUD that cannot be answered in small populations. In addition, I propose a secondary training goal of gaining
expertise in developmental neuroscience, to broaden the populations I can study to include children and
adolescents at-risk for SUD. Together, these skillsets will allow me to greatly expand the types of questions I
can ask, by allowing me to answer questions about SUD using both large observational data-sets, and also
targeted experimental manipulations (such as my R01). My goal at the end of this K02 to have the tools to not
only use big data to better understand risk factors and consequences of addiction in large samples, but also to
use this knowledge to inform future experimental studies and clinical trials that I can conduct in my lab.
The scientific focus of this application is a research project, using the publicly-available Adolescent
Brain and Cognitive Development (ABCD) dataset of 11,877 children scanned longitudinally, to understand
how trajectories of change in impulsivity associate with brain-based abnormalities and SUD risk. The aims for
the ABCD analysis project are to (1) define the factorial structure of impulsivity in the ABCD dataset as it may
portend SUD risk (using a confirmatory factor model which will be applied to the array of behavioral tasks, self-
report measures, and parent reports), (2) determine structural and functional brain measures that correlate with
impulsivity, and (3) examine how longitudinal changes in brain signatures of impulsivity are associated with risk
for SUD. To accomplish these aims, I will participate in courses and train with collaborators with expertise in
developmental neuroscience and in statistical analyses of big data. The skills I learn in the K02 period will be
used not only to query the ABCD dataset, but also to enhance the sophistication of neuroimaging analyses of
my R01 data and any future data collected in my laboratory. This training will enhance my laboratory by
significantly expanding the questions I can address, improving my analytic skills, furthering my ability to
collaborate, and providing a foundation for mentoring junior scientists. In the absence of K02 support, I will
need to cover my salary through teaching and administrative work, which would detract from my research,
training, and mentoring activities. This K02 award will provide protected time to develop my research program
and receive this training that will be critical for my career development as an addiction neuroscientist.

Public health relevance
Project Narrative This K02 Independent Scientist Award will provide protected research time for the PI to develop an integrated program of brain-based and behavioral research on substance use disorders (SUD), especially cannabis use disorder (CUD). This award will provide protected time for training in (1) statistical analysis as it pertains to big data, in light of the shift in the neuroimaging field toward large consortia-collected datasets, and (2) developmental neuroscience. This training will enhance the PI’s laboratory through significantly expanding the questions she can address, improving her analytic skills, furthering her ability to collaborate, and providing a solid and growing foundation for mentoring junior scientists.